Glycosyltransferase Function in Development and Disease

Summary
Glycosyltransferases generate covalent glycosidic linkages that include post-translational modifications to the
vast majority of secreted and cell surface glycoproteins. Mammalian sialyltransferases are a highly conserved
family of glycosyltransferases that attach sialic acids at distal and terminal positions during glycan synthesis
mostly as a2-3 and a2-6 anomeric linkages. Sialic acid linkages can form ligands of various receptors including
the Siglec receptors of immune cells. Siglecs bind sialic acids in cis and trans at cell surfaces thereby
controlling the assembly and signaling of immune cell receptor complexes. For example, Siglec binding to cell
surface sialic acid linkages induces immunological tolerance with the induction of B lymphocyte anergy and
apoptosis, which can block autoantibody induction and inhibit the onset of lupus-like autoimmune disease in
mouse models. The pathogenesis of autoimmune disease reflects defects in immunological tolerance but
remains poorly understood. Most mammalian cell surfaces are covered with glycoproteins bearing sialylated
asparagine-linked (N)-glycans. Unexpectedly, we have observed low levels of sialyltransferase expression and
sialic acids among normal mouse and human pancreatic beta cells. This intrinsically low level of sialylation
limits the expression of Siglec ligands and may be disadvantageous in the presence of a dysfunctional
hyperactive immune system. In Type 1 diabetes (T1D), a defect in immunological tolerance results in the
destruction of pancreatic beta cells. Although dysregulation of the immune system is believed to represent the
origin of this disease, the reason why pancreatic beta cells are targeted is not known. This research proposal is
focused on a unique hypothesis reinforced by significant supporting data that the susceptibility of pancreatic
beta cells to immunological attack in autoimmune diabetes reflects low levels of toleragenic sialic acids. To
identify the mechanistic features of immunological tolerance to pancreatic beta cells, we have initially studied
the Non-Obese Diabetic ShiLT/J (NOD) mouse because of its well-defined disease signs that include
spontaneous insulitis progressing to beta cell destruction, insulin deficiency and diabetes, and because of the
large body of immunological knowledge that has been acquired using this model of human T1D. We have
generated and analyzed transgenic syngeneic NOD mice bearing increased expression of sialic acids on
pancreatic beta cell glycoproteins. Remarkably, augmentation of sialic acid linkages protects NOD mice from
insulitis and the immunological destruction of pancreatic beta cells. The research proposed herein will compare
disease protection afforded by transgenic sialyltransferase expression augmenting a2-3 and a2-6 sialic acid
linkages and Siglec ligands in NOD beta cells, and complete transplant studies to gain mechanistic insights of
how sialic acids participate in immunological tolerance. Discovering the roles of glycosyltransferases in tissue-
specific autoimmunity will enhance the understanding of immunological tolerance mechanisms and is likely to
aid in the development of preventative and curative approaches to autoimmune diseases such as T1D.

Public health relevance
NARRATIVE This research addresses our recent discovery revealing that pancreatic beta cells have an unusual glycomic profile relatively deficient in the expression of sialic acids. Supporting data reveal that mice bearing augmented expression of immune tolerogenic sialic acids among pancreatic beta cells are protected from insulitis, hyperglycemia, and the immunological destruction in a mouse model of Type 1 diabetes. This proposal will investigate these findings that may explain the susceptibility of pancreatic beta cells to immune attack in triggering autoimmune disease and how to inhibit this disease process.